Defining the role of T cell help in germinal centers by intercellular enzymatic labeling

PROJECT SUMMARY
Generation of high affinity antibodies in germinal centers (GCs) is a critical step in a wide variety of clinically
relevant processes, from protection against pathogens by prior infection or vaccination to the development of
allergies and autoimmune diseases. Antibody affinity maturation follows a prototypical Darwinian framework, in
which GC B cells introduce random mutations into the antigen-binding portions of their immunoglobulin (Ig)
genes, generating variations in affinity within their progeny. Rare B cells that acquire affinity-increasing mutation
are then selectively expanded within the GC population, thus increasing the average affinity of GC B cells as a
whole, in a process we refer to as positive selection.
Despite decades of work, the precise cellular mechanisms of positive selection—in other words, how GCs “pick
out” B cells with the highest affinity—remains a topic of debate. More than 10 years ago, we provided the first in
vivo evidence in mice for a role for T follicular helper (Tfh) cells as arbiters of this selective process. In our model,
Tfh cells would sense how much peptide a B cell could present on its surface (which in turn depended on the B
cell’s affinity), providing help selectively to the highest-affinity B cells. However, despite accumulating functional
evidence for this model, selective delivery of T cell help to B cells based on their affinity has never been directly
demonstrated in physiological settings. To achieve this, we developed LIPSTIC, a method that allows us to
directly record T cell help to B cells with great precision in vivo. In Aim 1 of this project, we propose to use
LIPSTIC as a means to directly test the T cell help model in classic hapten-carrier induced GC selection models.
In Aim 2, we will follow up on this by testing our findings from mouse LIPSTIC in human vaccine-induced GCs.
In Aim 3, we use the original LIPSTIC in conjunction with two novel versions on this strategy to investigate the
dynamics of multi-antigen driven selection in influenza-induced GCs.

Public health relevance
PROJECT NARRATIVE B cells produce the antibodies that help us control infections and are the primary mechanism though which vaccines work. Although we understand well the general biology of B cells, the specific mechanisms by which antibodies evolve to become sufficiently potent to combat disease are not fully understood. The work proposed in this application will help us design vaccines that are better able to induce potent antibodies against pathogens such as influenza, HIV, and SARS-CoV2.